Sample collection and characterization studies of HIV variant strains for the Global HIV panels projects

The purpose of this agreement is to continue research at the FDA lab on HIV viral load determination and Next Generation whole genome sequencing (NGS) to characterize and analyze multiple, diverse isolates from different parts of the world for NIAID’s ongoing efforts to develop a well characterized repository for diagnostics, drug and vaccine studies.